Cell-type-specific neural circuit connectomes in the mouse models of aging and Alzheimer's disease

Project Summary
Alzheimer’s disease (AD) is the most common cause of progressive dementia in older adults, but there is no
cure for this debilitating condition. We hypothesize that aging and AD-related pathologies cause maladaptive
changes within hippocampal formation circuits that serve as connectome hubs for large numbers of critical brain
regions, ultimately leading to age- and AD-related cognitive deficits. In response to RFA-AG-22-008, we have
assembled a strong multi-investigator team across multiple institutions with complementary expertise in neural
circuit mapping, next-generation AD mouse model development, single-cell transcriptomics and epigenomics
analysis, and mouse brain common coordinate framework / atlas development. We will leverage the exceptional
resources offered by the UCI Center for Neural Circuit Mapping, the MODEL-AD Consortium and the Allen
Institute for Brain Science. We propose to perform large-scale, cell-type-specific mapping of hippocampal
formation circuits to generate cellular resolution connectome data that combines molecular and anatomical
annotations. To capture a more accurate composite of human AD features, we will use three complementary
AD mouse models including two next-generation AD mouse models. These include 1) the 5xFAD mouse model
with familial mutations, 2) the hAß-KI mouse that expresses human wild-type Aβ sequence from the endogenous
mouse App locus to model late-onset AD features, and 3) Trem2 R47H knock-in mice that model the increased
risk of the R47H coding variant for late onset AD. We will comprehensively map and characterize hippocampal
formation brain circuits, including CA1, the subiculum (SUB) and the entorhinal cortex (EC) that show earliest
neurodegeneration across AD mouse models and in human patients. These sub-circuits serve as hubs for neural
processing from many other cortical and sub-cortical brain regions. We will use genetically modified
transsynaptic neurotropic viruses developed by our team to map brain-wide anterograde and retrograde neural
networks. The brain connectomes generated from viral tracing experiments will be enhanced with spatially
resolved, single-cell transcriptomics-based molecular annotation using MERFISH (multiplexed error-robust
fluorescence in situ hybridization). We will identify molecular candidates that confer vulnerability versus disease
resistance as we superimpose spatial transcriptomic data on AD-modulated circuit connectomes. The entire
data set will be annotated using the Allen Mouse Brain Common Coordinate Framework to facilitate resource
and data sharing. Our work will improve our understanding of brain circuits susceptible to aging and AD towards
developing better early diagnostic tools and new treatment strategies for AD.

Public health relevance
Project Narrative Alzheimer's disease (AD) is an escalating major health concern in the United States. The proposed research will use cutting-edge neuroscience techniques to map vulnerable cell types and neural connectivity changes using mouse models of aging and AD. Our research meets multiple major goals of RFA-AG-22-008 and is expected to have high impact by providing critical reference information for molecular and neural circuit studies of multiple established and new AD models for the large AD research community.